CORE 2: IMMUNOLOGY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Immunology and Cell Analysis Core (ICAC) was established during the initial cycle of this COBRE to support the needs of the investigators. It has served a central role in developing the projects proposed in the first application and will continue to play a critical role in the advancement of the projects in the renewal application. The ICAC will serve the PJIs in several capacities including: training PJIs and laboratory personnel to operate instruments, provide technical support, assist in analyzing data, planning and running the experiments, and trouble-shooting protocols. The ICAC provides state-of-art instrumentation for standard immunoassays including multicolor flow cytometry, separation of cell subpopulaions, proliferation cytokine production, intracellular proteins, and cytotoxicity. It will also provide analysis for experiments related to single cells, nuclei and chromosomes, study of cell signaling such as phosphorylation events, calcium flux, and activation and translocation of nuclear transcription factors.